Post-Operative Biomarker-Guided Precision Medicine for Cardiovascular Risk Reduction

Project Summary/Abstract
Non-cardiac surgery (NCS) is a major iatrogenic stressor that can unmask subclinical cardiovascular (CV)
disease. Biomarker surveillance in the perioperative period of NCS identifies patients with unrecognized or
subclinical CV disease at risk of long-term adverse CV outcomes. Myocardial injury after NCS (MINS), defined
by a post-operative elevated troponin, with or without ischemic symptoms, is associated with short and long-
term CV complications and mortality. Unfortunately, treatment pathways to reduce long term CV risks after
non-cardiac surgery have not been defined in patients with MINS, limiting enthusiasm for biomarker screening.
The long-term goal of the proposed research is to carry out an international multisite randomized clinical
trial to evaluate perioperative biomarker-based precision care with targeted long-term use of a low-dose direct
oral anticoagulant and high-intensity statin therapy to improve CV outcomes in patients with MINS. The
successful design and execution of the future clinical trial is dependent on identifying study sites that are high
volume surgical centers with sufficient frequency of post-operative troponin surveillance, refinement of study
entry criteria and study interventions that will promote robust recruitment and study retention based on both
clinician and participant preferences, and demonstration of study feasibility through a pilot randomized
controlled trial. The current application proposes three objectives; for Objective 1, site surveys will be
designed and distributed to acquire data on the number of potential participants with MINS at potential study
sites, approaches to perioperative biomarker surveillance, current post-operative management of MINS, and
potential barriers to enrollment. For Objective 2, questionnaires based on clinical scenarios will be designed
and distributed to characterize clinician equipoise for treatment based on post-operative cardiac biomarkers
overall and according to demographics, biomarker thresholds, clinical risk factors, surgical subtypes, and
bleeding risks. For Objective 3, a pilot randomized trial of low-dose direct oral anticoagulant and high-intensity
statin versus usual care in 50 patients with MINS will be conducted to determine enrollment feasibility and
adherence to therapy at 2 months. A mixed methods approach that integrates qualitative data collected from
patient interviews and quantitative methods based on Best-Worst scaling surveys and discrete choice
experiments will be implemented to determine patient preferences for therapy after non-cardiac surgery (based
on attributes including CV benefit, bleeding risks, convenience and costs). The data obtained for each of the
objectives will be used to assess feasibility and optimize study design (entry criteria, study endpoints, sample
size calculation, site selection) and recruitment strategies for the future randomized clinical trial studying
biomarker-based care in post-operative patients at elevated CV risk.

Public health relevance
Project Narrative Cardiac complications are a major cause of death or disability after surgery unrelated to the heart. Blood markers suggestive of heart damage are commonly detected after surgery, even among asymptomatic patients. This planning grant aims to gather information to support the design and execution of a clinical trial to determine the best long-term medical treatment for patients who have abnormal blood markers indicative of heart damage after surgery in order to improve long-term survival and reduce the risk of heart disease-related complications.